Molecular analysis of pediatric cardiomyopathy

In families with inherited cardiomyopathy, gene loci will be mapped, candidate genes isolated, and mutations discerned. In fatty acid oxidation disorders, mutations will be determined and correlated with phenotype(s).